Development of a Novel Virtual Reality Treatment for Emerging Adults with ADHD

Project Summary/Abstract
Attention deficit hyperactivity disorder (ADHD) is a highly prevalent and impairing disorder. Behavioral
treatments that structure the environment and provide frequent and consistent monitoring are efficacious but
resource and time intensive, leading to problems with access and adherence. This study will utilize a virtual
reality platform to minimize distractions and provide the structure and monitoring necessary for individuals with
ADHD to maintain focus while completing homework and studying. The virtual reality (VR) headset will place
students in a distraction free environment that automates the frequent and consistent point-of-performance
feedback and reinforcement that serves as the core mechanisms of behavioral treatment. The VR technology
will allow for direct comparison between two novel intervention approaches and a VR passthrough to laptop
control. Survey and objective data (keyboard and mouse click data) will be collected to directly evaluate the
impact of VR on core targets of action, including concentration, motivation, and homework effort. This novel
alternative to medication and behavior therapy offers a completely new tool for supporting individuals with
ADHD. This study includes four separate projects, three in the R61 phase and a large randomized trial in the
R33 phase. Project 1 (N = 30 college students with ADHD) focuses on optimizing and refining objective data
capture algorithms to quantify on-task behavior and work productivity while completing a variety of different
types of academic tasks. Project 2 (N = 30 college students with ADHD) focuses on developing and refining
on-task monitoring and performance feedback algorithms within VR, including a green, yellow, and red-light
display that allows individuals with ADHD to receive consistent and frequent feedback and work towards
specific short-terms goals and rewards. Focus groups will also be completed to improve VR feasibility and
usability. Project 3 involves a small randomized controlled trial to ensure that the key targets of action are
engaged. Project 3 will assess the feasibility/usability and preliminary effects of the VR environment alone
(n=15) as compared to VR environment + contingency management (n=15) and a passthrough control wearing
of the VR headset (n=15). Time on-task, homework motivation, and homework effort are the proposed
mechanisms of action. If the Go/No-Go criteria are met in Project 3, the protocol moves to Project 4, which
involves a randomized trial of the VR intervention. 252 college students with ADHD will be randomized to
receive either: (1) VR environment alone, (2) VR environment + contingency management, or (3) pass-through
VR headset control for 8 weeks. Measures of mental health and academic functioning will be collected at
baseline, 4 weeks, 8 weeks, and at a 3-month follow-up.

Public health relevance
Project Narrative Virtual reality can provide a distraction free and engaging environment and automate point-of-performance monitoring and feedback of concentration and focus. Virtual reality may provide a novel way to provide high impact behavioral treatment to address the significant difficulties with attention, motivation and work efficiency experienced by individuals with attention deficit hyperactivity disorder.